Spoken Language Processing as an Early Marker of Language Impairment in Bilingual Children

PROJECT SUMMARY/ABSTRACT
Developmental language disorder (DLD) affects 6-8% of children and has impacts on academic, social, and
economic outcomes throughout life. Early identification of children at risk for DLD is critical to improving long-
term outcomes. However, for the large number of bilingual children in the United States, early signs of DLD
can be difficult to recognize. A key challenge in identifying bilingual toddlers at risk for DLD is that current
measures cannot differentiate between delays in accumulated language knowledge – which can result from
reduced exposure to each language – and “true” impairments in language learning and processing that are
likely to result in persistent problems. Measures of language processing offer a promising approach to
identifying DLD in bilingual populations, as they try to capture underlying deficits while minimizing the effects of
prior experience. This study will use fine-grained measures of spoken language processing to compare the
performance of Spanish-English bilingual toddlers with low expressive vocabularies (“late talkers”, n=40) and
typical expressive vocabularies (“typically developing”, n=40), and to examine associations between language
processing and vocabulary growth over the third year of life in both groups. Children will be followed
longitudinally from 24 to 36 months with measures of vocabulary (via parent report) and language processing
(using eye-tracking) in Spanish and English. The overarching goal is to determine whether language
processing efficiency is an early marker of DLD in bilingual toddlers. Aim 1 will use eye-tracking measures to
compare the performance of typically developing and late-talking bilingual toddlers in familiar word recognition
at 24 and 30 months. Aim 2 will use eye-tracking methods to compare the performance of typically developing
and late-talking bilingual toddlers in novel word learning at 24 and 30 months. Aim 3 will determine the extent
to which measures of language processing and vocabulary at age 2 predict trajectories of vocabulary growth
across the 3rd year in both typically developing and late talking bilingual toddlers, as well as their performance
in standardized tests of vocabulary knowledge at age 3. The working hypothesis is that measures of familiar
word recognition and novel word learning will improve prediction of language outcomes over measures of
vocabulary alone, and will help identify bilingual LTs who remain delayed at age 3. This represents the first
investigation of the language processing skills of bilingual late talkers, and of the extent to which these skills
predict their lexical development. Completion of study aims will inform the development of methods for early
identification of DLD in bilinguals and will advance theoretical understandings of the mechanisms underlying
language impairments more generally.

Public health relevance
NARRATIVE (Public Health Relevance) Developmental language disorder affects 6-8% of children and has long-term impacts on education, health, and well-being. Early identification of children at risk for language impairment is critical for improving long-term outcomes. However, current methods for identifying risk for language impairment in bilingual toddlers are inadequate. The goal of the proposed research is to investigate whether experimental measures of spoken language processing can serve as an early marker of language impairment in bilingual children at 2 years of age. This research will advance the development of methods for early identification of language impairment in bilingual children, a critical step towards prevention and treatment of language impairments in this underserved population.